Suicidal Behavior among Adolescents Experiencing Homelessness in the US during the COVID-19 Pandemic

PROJECT SUMMARY
Suicide is a major public health problem in the U.S., ranking as the second leading cause of death among
teens, with a rate of 7.1 per 100,000 population in this age group. Previous studies have revealed seasonal
trends and day-of-the-week effects in adolescent suicidal behavior, such as higher incidence in spring, on
Sundays, and on Mondays, and lower occurrences in summer, aligning with the school calendar. A significant
gap in understanding suicidal behavior exists among adolescents experiencing homelessness (AEH), who
show higher rates and distinct seasonal patterns and day-of-the-week effects compared to their domiciled
counterparts. Our previous research showed that AEH face increased risk when away from school, evidenced
by an attenuated summer decline in suicide attempts and peak suicide deaths in summer and the beginning of
the weekend (i.e., Fridays and Saturdays). The pandemic brought new challenges, such as economic
instability, limited access to essential services, and increased social isolation, which may have
disproportionately affected the vulnerable population of AEH. We hypothesized that the pandemic has
exacerbated existing disparities between AEH and their domiciled counterparts. Additionally, recent studies
reported decreased rates in suicidal behavior among adolescents in spring 2020, coinciding with nationwide
implementation of school closures as a pandemic control measure. However, no research has focused on AEH
during this time. Expanding on our prior study that showed a higher risk for AEH when they are away from
school, we hypothesize that suicidal behavior increased among AEH in spring 2020. To test these innovative
hypotheses, we will analyze three linked datasets: 1] Homeless Management Information System (HMIS) data;
2] hospital discharge records; and 3] death records from five jurisdictions, which collectively represent 32.5% of
AEH in the U.S. and 10.8% of the U.S. adolescent population. Adolescents aged 13 to 17 will be analyzed due
to distinct suicidal behavior mechanisms within this age group compared to younger children and older
adolescents. For example, adolescents younger than 18 are subject to distinct stressors related to school
enrollment, whereas some individuals above 18 are not in school. The circumstances surrounding
homelessness may differ as well, with those below 18 often accompanied by parents and those above 18 often
living independently. Aim 1 will investigate differences in annual rates of suicidal behavior among AEH and
domiciled adolescents between 2016 and 2022 to determine whether the pandemic has exacerbated existing
disparities between the two groups. Aim 2 will assess monthly trends in suicidal behavior before, during, and
after the pandemic to determine whether suicidal behavior increased among AEH in spring 2020. Investigating
trends in suicidal behavior among AEH during the pandemic will inform whether suicide prevention measures
tailored to AEH are needed, especially before and during school breaks. The findings will also enhance
preparedness for potential school closures due to future pandemics.

Public health relevance
PROJECT NARRATIVE Adolescents experiencing homelessness (AEH) have higher rates of suicidal behavior compared to their domiciled counterparts, especially during school breaks (i.e., summer, Fridays, and Saturdays), while their domiciled counterparts have lower rates during these periods. Although recent studies noted decreased rates of suicidal behavior among adolescents in spring 2020, coinciding with nationwide school closures as a pandemic control measure, we hypothesize increased suicidal behavior among AEH in spring 2020 based on our prior study indicating AEH face higher risk when away from school. The proposed project will investigate annual rates of suicidal behavior among AEH and domiciled adolescents from 2016 to 2022 to determine whether the pandemic has exacerbated existing disparities, as well as assess monthly trends before, during, and after the pandemic with the goal of informing tailored suicide prevention measures for AEH, especially before and during school breaks, and enhancing preparedness for potential future school closures due to pandemics.